PSYCHOMETRIC AND NEUROLOGIC EVALUATION IN IMMUNODEFICIENCY VIRUS INFECTION

Psychometric, neurologic and CSF examinations of patients infected with HIV are correlated with each other, and compared with followup evaluations to assess the development of neurologic complications of AIDS.